Immune System Aging in Parkinson’s and Alzheimer’s disease: Epigenetics, biologic aging, and heightened immune states in a population-based study

PROJECT ABSTRACT.
Kimberly Paul, PhD, MPH, is a neurologic and aging disease epidemiologist whose research career goals focus
around using modern, “omic” technologies to define the neurodegenerative disease process and elucidate risk
at a biologic level, integrating a systems biology approach, in population-based studies. The research she
proposes, entitled “Immune System Aging in Parkinson’s and Alzheimer’s disease-related dementia:
Epigenetics, biologic aging, and heightened immune states”, combines advanced statistical methods and
a systems biology modeling approach with high-throughput omics markers to study immune system aging in
neurodegenerative disease patients relative to community-based controls; followed by relating epigenetic
markers of inflamm-aging to symptom development and multiple metabolomics measurements over time.
Candidate & Mentoring Team: Dr. Paul is a Postdoctoral Scholar in the Department of Epidemiology at the
Fielding School of Public Health (UCLA) and will transition to an Assistant Professor in the Department of
Neurology, David Geffen School of Medicine. Dr. Paul was previously awarded an NIEHS F32 to investigate how
metabolic dysfunction mediates the association between ambient environmental exposures and primarily
Alzheimer’s disease-related dementia (ADRD). For this work, she was awarded the prestigious Chancellor’s
Award for Postdoctoral Research at UCLA. Her research priorities have developed into bringing biology and
mechanism into population and data science. The proposed career development plan will build upon her previous
training with goals to enhance her trajectory toward becoming an independent investigator, including experiential
and didactic learning in design, methods and data interpretation, while developing the leadership and
professional skills required to lead an independent research lab and execute an R01. Dr. Paul has assembled a
strong mentoring team with renowned expertise, commitment, and available resources to support her training.
Research Summary: The research aims of this K01 proposal focus on using a systems biology pipeline to
investigate immune system aging in Parkinson’s disease (PD) and ADRD patients, using blood-based
epigenetics to define immune states. The purpose of this proposal is to investigate how these immune markers
and measures of accelerated immune system aging relate to onset, symptom development, and trajectories of
metabolomic changes using two population-based studies. The hypothesis being that immune profiles which
reflect “inflamm-aging” (chronic, low-level inflammation states) and immunosenescence will be related to faster
symptom development. Furthermore, longitudinal metabolomics and targeted gene sequencing will give insight
into endogenous risk and the systemic response related to different immune states as symptoms develop.
This award will provide Dr. Paul the research opportunity and career development resources to continue to excel
and establish herself as an independent investigator and leader in her field, conducting innovative research,
combining systems biology, omic technologies, and population-based research.

Public health relevance
PROJECT NARRATIVE. Key aging-related immune system changes (immunosenescence) combined with chronic, low-level inflammation states, termed inflamm-aging, have been increasingly related to neurodegenerative changes, both in the central nervous system and peripherally. The aim of this proposal is to combine advanced statistical methods and a systems biology modeling approach with high-throughput omics markers (blood-based epigenetics and metabolomics) to study immune system aging in neurodegenerative disease (AD and PD) patients relative to community-based controls. And importantly, relate markers of heightened immune states and faster inflamm- aging to longitudinal disease progression, including symptom development and multiple metabolomics measurements over time.